The Role of Cancer Associated Fibroblasts in LIN28B mediated Colorectal Cancer Metastasis

PROJECT SUMMARY
Differentiation is a fundamental process underlying cellular identity and plasticity. Traditionally, differentiation is
a transition between less committed/specialized cell states into more committed/specialized state, and this is
believed to be unidirectional. Differentiation is evident in development, division of stem cells, homeostasis or
normal turnover, regeneration following injury, and malignant transformation. Clusters of differentiated cells are
necessary for tumor cell invasion (collective invasion), intravasation, circulation, extravasation and metastasis
(colonization in a distant organ). We have unraveled the critical function of LIN28B (human), an RNA binding
protein, as a master regulator of reprogramming of differentiation in colorectal cancer (CRC) and metastasis.
Indeed, LIN28B plays essential roles in embryonic stem cell differentiation and inducible pluripotent stem cell
differentiation but its role in tumor metastasis is not elucidated. Having published that Lin28b (mouse) is
oncogenic in a genetic mouse model with the induction of colonic adenomas and CRC, and about one-third of
human CRC cancers overexpress LIN28B (in turn associated with worse outcomes), we have determined that
LIN28B induces the CDX2 transcriptional factor in promoting primary CRC differentiation. In addition, we have
new evidence that LIN28B directly targets Claudin-1 (CLDN1) mRNA to foster the formation of tight junctions
and cell-cell adhesion, which in turn induces NOTCH3 to modulate metastasis to the liver. We also have new
evidence that Lin28b endows in vivo mouse orthotopically implanted tumoroids that harbor Apc/Kras/p53
mutations to metastasize to the liver as they do not metastasize without Lin28b. Thus, we are defining new
mechanisms that reveal how LIN28B promotes differentiation at the primary CRC site and then leverages
previously unappreciated mechanisms to promote metastasis. We hypothesize that LIN28B promotes primary
CRC differentiation and mediates metastasis through induction and maintenance of a tumor differentiation
program that may involve distinct subclones destined for metastasis. This hypothesis will be pursued through
the following in vivo physiologically relevant interrelated Specific Aims: (1) To identify the molecular
mechanisms by which CLDN1 facilitates CRC metastatic progression in the context of LIN28B overexpression,
with NOTCH3 being an attractive target and determination of other targets; (2) To determine the contribution
of Lin28b to invasion, circulation and distant organ (liver) colonization in a syngeneic in vivo trackable model
of metastatic CRC, allowing us to span the entire metastatic cascade; and (3) To identify subpopulations in
primary CRC, potentially fated for metastasis (e.g. those cells that may display hybrid/partial EMT), and
determine the dependence of their phenotype on Lin28b by integrating single-cell RNA-seq with lineage tracing
(bar-coding). Our novel, mechanistic findings and innovative approaches allow us to provide insights into the
fundamental aspects of cellular differentiation in the context of primary CRC, and elucidate why such
differentiated tumor cells have a proclivity for metastasis, and thus address gaps in the field.

Public health relevance
PROJECT NARRATIVE Differentiation is a fundamental process evident in a variety of cell states and transitions. Differentiation is a common feature in tumors, which is most pronounced in colorectal cancer, a vexing health problem. We seek to elucidate how LIN28B, an mRNA binding protein, fosters differentiation in colorectal cancers and concurrently, promote metastasis in this differentiated state.